Administrative Core

Admin Core
The Admin Core will organize ERCP investigator meetings and facilitate DMRR interactions within the
Consortium and with the broader community. Investigator meetings will occur twice per year and consistent of
oral presentations, workshops, poster sessions, breakout meetings, and round table discussions. We will
develop meeting content in close collaboration with the Consortium Steering Committee and solicit input from
ERCC investigators. Admin Core will work directly with hotel management to arrange all meeting logistics, and
also develop web-based meeting and workshop registration sites. We will also aim to facilitate Consortium and
community interactions by running a monthly seminar series where researchers present their exRNA related
work and post their presentation to the exRNA Portal.